Using mixed methods to reduce disparities in renal colic care: a model for surgical value transformation

PROJECT SUMMARY
Value-based purchasing (VBP) reforms in the United States (e.g. pay-for-performance) seek to improve care
efficiency by reducing wasteful health care practices, which may harm patients and account for ~30% of the $4.1
trillion spent annually on US healthcare. Surgical care, which comprises over 50% of Medicare spending, is a
logical target for these reforms given it’s episodic and cost-intensive nature. However, surgical episodes are
targeted by just one-third of VBP arrangements, none of which have achieved net cost savings. As such, there
is a critical need to identify novel models of surgical care that provide insights/solutions to the failings of existing
surgical VBP efforts. Symptomatic urinary stone disease—aka renal colic—is a common (1 in 10 US adults) and
costly ($10 billion annually) surgical condition characterized by high levels of variation in perioperative outcomes
and costs, making it a condition ideally suited to evaluate drivers of perioperative care variation.
Current surgical VBP arrangement shortcomings may in part be due to misguided policies that reward strategies
seeking to minimize post-operative care variation rather than streamlining the sequence of episode-specific
clinical events preceding surgery. For example, there is growing literature demonstrating an association between
improved pre-operative functional status and post-operative health outcomes. Similarly, addressing patients’
social needs ahead of surgery appears to improve 30-day post-operative outcomes. Consequently, developing
and deploying value-based interventions in the pre-operative period that target clinical and non-clinical risk
factors may be particularly effective at reducing variation in perioperative care, and by proxy surgical disparities.
This proposal will employ an explanatory sequential mixed-methods design using a combination of claims data
and patient/provider interviews to 1) identify social risk factors associated with variation in both pre- and post-
operative expenditures/outcomes related to an episode of renal colic (Aim 1), 2) assess patient/provider
perspectives on facilitators/barriers to timely and effective surgical care provided for an episode of renal colic
(Aim 2), and 3) design and pilot a clinical decision support tool that personalizes follow-up for patients discharged
from the emergency department with renal colic and who will subsequently undergo surgery (Aim 3).
Ultimately, these efforts will 1) inform how social risk impacts surgical outcomes, 2) align surgical VBP efforts
with the patient-provider experience, and 3) serve as the basis for a future R01-funded trial assessing the impact
of a risk-adjusted clinical decision support tool on perioperative outcomes/expenditures following a renal colic
diagnosis.

Public health relevance
PROJECT NARRATIVE United States value-based reforms targeting surgical conditions have had a modest effect on perioperative costs and outcomes, which may be related to misguided policies that reward strategies seeking to minimize post-operative care variation rather than streamlining the sequence of episode-specific events preceding surgery. Reframing current value-based surgical reforms to capture both patient/provider perspectives and a broader set of episode-specific clinical and non-clinical events will have the dual effect of improving surgical value and better aligning policies with patient/provider needs. By employing a mixed methods approach to surgical episode modeling and evaluation, this proposal will lay the foundation for a future clinical decision aid that targets at-risk populations with structural interventions to improve surgical value by reducing variation in perioperative care intensity and duration.